Mechanism and function of transplacental IgD

Project Summary
Allergies are becoming a major cause of neonatal morbidity, with food allergies showing increased incidences
and significantly affecting young infants, some of which can be serious or fatal, and are associated with long-
term morbidity, imposing heavy social and economic burdens. For neonatal food allergy, no effective treatment
is currently available except avoiding or replacing the offending food, which is often impossible due to the
ubiquitous nature of some food components. Hence, there is a critical need to identify effective means of
strengthening the immune function of neonates to improve their immediate and long-term health. Human
respiratory mucosa and blood harbor secreted immunoglobulin D (IgD). We found that IgD is important in
respiratory immune defense by inhibiting mucosal adhesion of pathogens and activating antimicrobial and
immune-amplifying functions of basophils. IgD activation of basophils also suppresses IgE-induced allergic
functions, and increased food allergen-specific IgD production correlates with protection against food allergy
after oral immunotherapy in children. Maternal tetanus, diphtheria, and acellular pertussis (TDaP) vaccine and
food exposure in pregnancy induces the production of vaccine- and food-specific IgD that is transferred across
the placenta to the fetus in humans and mice. The objectives here are to understand the mechanisms of the
placental transfer of IgD and to determine if maternal IgD promotes neonatal immune protection against food
allergy. We hypothesize that maternal IgD specific to vaccines or food acts as a specific and prophylactic fetal
immune education cue to protect neonates against food allergy. Of note, the basophil-activating and anti-
allergic functions are unique to IgD and not possessed by IgG. Employing biochemical and imaging techniques
in cell culture, human placenta specimens and mouse models, studies in Aim 1 will mechanistically elucidate
the placental transfer of maternal IgD. Aim 2 will determine the function of maternal food-specific IgD in the
protection against IgE-mediated neonatal food allergy by integrating neonatal mouse models of IgE-mediated
food-induced anaphylaxis with human cord or peripheral blood specimens of newborn babies with or without
food allergy in the first year of life. Our study is expected to reveal the unique functions of maternal IgD, an
ancient yet still mysterious antibody, in neonatal immune function that maternal IgG does not have, but also
have a profound impact on improving neonatal health by directing the design of IgD-targeting maternal
vaccines or adoptive immunotherapies.

Public health relevance
Project Narrative Allergies are major causes of pregnancy complications and neonatal morbidity. This project explores the function of maternal IgD transferred to the fetus during pregnancy in the protection from neonatal allergy. The novel scientific concept and clinical implications of this project fit well both the scientific and public health goals of NIH, and will have a significantly positive impact on how to innovatively and more efficiently tackle early infant morbidity due to increasing incidences of allergies.